NYU Center for the Study of Asian American Health

Project Summary/Abstract
Established in 2003, the NYU Center for the Study of Asian American Health (CSAAH) is an NIMHD
Center of Excellence (COE) focused on understanding, addressing, and reducing Asian American health
disparities through rigorous, transdisciplinary, and community-engaged research. CSAAH's scientific tracks
are: 1) cardiovascular disease and diabetes; 2) cancer; 3) mental health, and 4) pilot projects. The specific
aims of CSAAH are to: 1) Support a robust scientific infrastructure within NYU that stimulates community-
engaged translational research focused on minority health and health disparities; 2) Use participatory
approaches in developing and strengthening multi-sectorial community partnerships to advance health equity
and eliminate health disparities among Asian American populations; 3) Develop, conduct, evaluate, and
disseminate community-engaged, rigorous research to understand, address, and eliminate health disparities in
the Asian American population; 4) Provide a mentored, supportive research environment to post-doctoral
fellows, junior investigators, and early career investigators and stimulate career advancement opportunities in
minority and health disparities research; and 5) Serve as a national information and dissemination resource in
the translation of evidence-based research into community and clinical practice relevant to the social,
environmental, and biological needs of Asian American communities. The full research studies, one on
diabetes and the second on stomach cancer, aim to address the knowledge gap in sustainable, scalable health
interventions coordinated with health care systems and community-based providers. Informed by social
determinants of health, theory-based behavioral change and implementation science frameworks, we will use
innovative and rigorous approaches to harness the power of community health workers, technology, and
electronic health record-based strategies in ways that have not been adapted or systematically tested among
Asian American communities to improve access to care. To enhance the mental health research depth and
expertise, we will formalize a new partnership with the Nathan Kline Institute for Psychiatric Research, Center
for Research on Cultural and Structural Equity in Behavioral Health to support mental health disparities
research. For each scientific track, we will develop and test integrated and sustainable interventions aimed to
build on community assets, and improve structural competency to improve health care access and reduce
chronic disease disparities among Asian Americans. We will work towards strengthening the next generation of
minority and health disparities researchers through our career development and Pilot Project Program. Finally,
in partnership with the Asian & Pacific Islander American Health Forum, we have developed an innovative
model for community engagement and dissemination of evidence-based health interventions and information
that cuts across diverse Asian American populations in different community and practice settings.

Public health relevance
PROJECT NARRATIVE As an NIMHD Specialized Center of Excellence, the NYU Center for the Study of Asian American Health (CSAAH) aims to eliminate health disparities and advance health equity among Asian American populations, with scientific tracks focused on: 1) cardiovascular disease and diabetes; 2) cancer; 3) mental health, and 4) pilot projects aimed to support formative and innovative research. Research in these tracks integrate the role of social determinants of health, utilize participatory research approaches, support practice and policy translation, and are actively engaged in community and scientific dissemination. A robust Pilot Project Program linked to mentorship and career development opportunities will stimulate minority and health disparities research interest, competence, and a new generation of diverse, skilled researchers in the field.